The role of TREM2 in Alzheimer's disease related neuropathogenesis in people with HIV

Summary/Abstract
This R01 application is for a 5-year project to investigate the role of triggering receptor expressed on myeloid
cells (TREM) 2 in Alzheimer's disease pathogenesis in people with HIV (PWH). Alzheimer's disease is the
leading cause of dementia in the USA, yet despite many efforts, the cause remains unknown. Some evidence
suggests that viral infections can trigger neuropathogenic cascades that lead to Alzheimer's disease.
Consistent with this hypothesis, HIV infection is associated with premature aging and may increase the risk for
age related neurodegenerative diseases such as Alzheimer's disease and amnestic minor cognitive
impairment (aMCI). Our group and another group independently discovered reduced levels of TREM2 in the
central nervous system of PWH. This was as significant discovery because TREM2 is an immunomodulatory
receptor expressed by brain macrophages: microglia, perivascular macrophages, and infiltrating monocyte
derived macrophages. Functional TREM2 surveys the brain for extracellular protein aggregates (Ab) and
injured cells and modulates inflammation. Loss of function mutations in TREM2 are associated with increased
risk for Alzheimer's disease. Alzheimer's disease-like pathology, including increased inflammatory cytokine
expression and increased Ab, has been reported in postmortem brains of PWH. Despite these findings, how
TREM2 functions in the brain during HIV-infection is unknown. Our new preliminary findings show that HIV
infection and related inflammatory stimuli can alter TREM2 levels in macrophages. This mechanism for
reduced TREM2 function may explain the published reports of increased levels of Ab and increased levels of
inflammatory cytokines in postmortem brain tissues from PWH with neurocognitive impairment (NCI) compared
to neurocognitively unimpaired (NUI) PWH. We also found that cannabinoids at appropriate doses can
enhance TREM2 pathway expression and function in macrophages, which could explain why cannabis shows
neuroprotective and anti-inflammatory effects in PWH. Understanding how HIV infection may lead to TREM2
dysfunction and Alzheimer's disease-like neuropathogenesis may provide clues to develop therapeutics for
these neurodegenerative diseases. Therefore, we hypothesize that HIV modulates TREM2 signaling
pathways in a manner that exacerbates neurodegeneration and inflammation, thereby accelerating
Alzheimer's disease-like pathogenesis in PWH. This project aims to delineate the specific mechanisms by
which HIV alters TREM2 function, exploring innovative pathways that may reveal novel therapeutic targets.
This hypothesis will be tested in mice that model the intersection of aging, HIV, and AD neuropathogenesis
(Aim 1), in cell culture models for brain macrophages after exposure to HIV, ART, and inflammatory stimuli
(Aim 2), and in post-mortem brain tissues from PWH and people without HIV (PWoH), both with and without
NCI and aMCI (Aim 3).

Public health relevance
Project Narrative Worldwide, over 34 million people are infected with HIV, and as high as 50% of HIV patients are affected by HIV- associated neurocognitive disorders (HAND), despite the success of antiretroviral therapy (ART). As these patients live longer with ART, they face increased risk of age-related comorbidities, such as the development of Alzheimer's Disease. The proposed studies will probe underlying mechanisms of HIV-induced neurotoxicity that may lead to novel therapeutic interventions for HAND and other neurodegenerative diseases.